Resource Use and Quality of Care in Medicare Advantage

Project Summary
Medicare Advantage (MA) is a private alternative to the Traditional Medicare (TM) program. MA has
grown substantially in recent years, covering more than one-third of the Medicare population. MA is
Medicare’s most important effort to create financial incentives for providers to deliver efficient care.
Whether MA delivers care more efficiently than TM has long been an important inquiry. However, the
existing work is limited in important ways. Notably, it provides little information on MA’s care provision
for patients with serious and complex conditions, whose care relies heavily on specialists (“specialist-
heavy conditions”). This is a significant gap because those conditions have serious health outcomes
and high costs. In addition, the existing work shows that MA reduces costs by shifting care provision
toward services delivered by primary care physicians (PCPs), but the work offers little insight into
whether those shifts are a viable option to deliver efficient care for specialist-heavy conditions. This
project will provide the first evidence on MA performance for specialist-heavy conditions – key
information needed to assess implications of MA growth for patient care. The study will compare
resource use and quality of care between MA and TM for five specialist-heavy conditions that have
important cost and health impacts: two conditions where MA’s ability to modify the amount of PCP care
is limited due to care standardization and three conditions that present opportunities for MA to increase
PCP involvement in care compared with TM. The project will examine whether MA performs better than
TM when it shifts care provision toward PCP services. It will thus validate whether a channel by which
MA improves efficiency in care is viable for specialist-heavy conditions. This is a key to identifying
opportunities to improve care delivery for those conditions. The study will address sample selection
related to MA enrollment using an instrumental variable (IV) approach – a rigorous method to obtain
unbiased estimates.

Public health relevance
Project Narrative Medicare Advantage (MA) offers beneficiaries an option to receive Medicare benefits from private plans instead of enrolling in the Traditional Medicare (TM) program. The proposed project will examine resource use and quality in MA relative to TM for serious conditions who care relies heavily on specialist and will assess whether MA reduces resource use without harming quality when MA increases primary care physicians’ involvement in care for those conditions compared with TM. The project will offer important information needed to assess implications of MA growth for patient care and find opportunities to improve efficiency in care delivery in Medicare.